A Heart Rate Variability Biofeedback Enhanced Behavioral Intervention to Improve Psychological and Disease Functioning in Youth with Inflammatory Bowel Disease (IBD)

PROJECT SUMMARY
Inflammatory bowel diseases (IBD), including Crohn’s disease and ulcerative colitis, are immune-mediated
gastrointestinal disorders associated with chronic medical and psychosocial dysfunction. IBD is increasingly
conceptualized as a product of the bidirectional communications between the central nervous system, the
autonomic nervous system (ANS), and the gut, referred to as the brain-gut axis. Consistent with this model,
adolescents with IBD demonstrate dysfunction of the ANS indicative of a chronic stress response and are at
increased risk for chronic psychological distress characterized by anxiety and depression. Treating ANS
dysfunction has emerged as a common and relatively easy to treat target to reduce psychological symptoms
as well as potentially ameliorate the disease symptoms of IBD. Through our prior work with pediatric IBD
patients, we have demonstrated that heart rate variability (HRV) is a non-invasive, acceptable, and feasible
measure of ANS functioning that we can reliably assess in youth with IBD and treat through HRV biofeedback.
In our prior work, we developed and evaluated the feasibility, acceptability, and preliminary efficacy of a
virtually delivered, group-based HRV biofeedback-enhanced coping skills treatment program for adolescents
diagnosed with IBD (K23DK122115). The goal of the proposed work is to build upon compelling preliminary
findings to test intervention efficacy via a randomized waitlist-controlled trial of our HRV biofeedback-enhanced
coping skills treatment program in a sample of adolescents ages 13-18 diagnosed with IBD and who screen
positive for symptoms of anxiety and/or depression; n = 128. The treatment program is based on evidence-
based cognitive behavioral therapy treatment principles and uses HRV biofeedback as an adjunctive treatment
component to treat autonomic dysfunction. With R01 support, our multidisciplinary team of experts in
behavioral interventions incorporating HRV biofeedback, pediatric IBD, and clinical trial design will determine if
treatment (1) improves psychological outcomes and (2) symptoms of IBD including reductions in disease
activity and inflammatory markers, relative to controls. Further, we will determine the mechanistic role of HRV
on psychological and IBD symptoms as a function of treatment. Support for a virtually delivered, HRV
biofeedback-enhanced coping skills treatment program for youth with IBD to address psychological outcomes
and symptoms of IBD would provide a scalable, innovative treatment option for the growing number of affected
pediatric patients. Further, if successful, we will demonstrate that HRV is a modifiable biomarker of autonomic
dysfunction responsive to biofeedback training and mechanistically responsible for intervention effects on
psychological and clinical outcomes as well as markers of inflammation.

Public health relevance
PROJECT NARRATIVE Consistent with a brain-gut axis conceptualization of disease, adolescents diagnosed with inflammatory bowel disease (IBD), including Crohn’s disease and ulcerative colitis, are at increased risk for dysfunction of the autonomic nervous system indicative of a chronic stress response as well as psychological distress characterized by anxiety and depressive symptoms. This randomized waitlist-controlled trial will test efficacy of a virtually delivered, group-based coping skills treatment program incorporating heart rate variability biofeedback to target autonomic dysfunction. The long-term goal of this research is to provide a scalable, innovative behavioral treatment option for the growing number of pediatric patients affected by IBD to treat psychological distress and disease activity.